Mechanisms of transition from pre-malignancy to cancer in the Brca1-mutant breast

SUMMARY – Project 3
Women with deleterious mutations in the breast cancer susceptibility gene BRCA1 have a high risk of developing
breast cancer. Standard of care is risk-reducing mastectomy which is a painful procedure that often results in
significant clinical complications, therefore the development of targeted therapy approaches for cancer
prevention in these patients are desperately needed. BRCA1 encodes a protein with pleiotropic functions and
most of its tumor-inducing role has been associated with its DNA repair function. Early studies suggested that
genome instability is the main cause of tumor initiation in BRCA1 mutation carriers, but clinical observations and
functional studies in animal models indicate that non-genetic mechanisms are also critical for cancer initiation.
To identify potential non-genetic drivers, in preliminary studies we used a combination of single cell RNA
sequencing and spatial genomics approaches to perform detailed characterization of the cellular and molecular
changes that occur during tumor progression in a Brca1/p53 deficient mouse model of the disease. Our most
striking finding is the presence of epithelial cells with a hybrid phenotype that co-express markers of both basal
and luminal cells (termed basal-luminal intermediate, BLI cells). These cells appear in pre-malignant tissues and
expand to constitute tumors. Our single cell analysis also revealed alterations in activin signaling, an important
regulator of epithelial proliferation in the mammary gland, as well as alterations in the immune microenvironment
in pre-malignant tissues. Utilizing mathematical modeling, we found that if these events are combined, they
should be sufficient to induce tumor initiation at very low probability, which is consistent with observations in mice
and humans that tumor initiation is a rare event that occurs after a prolonged latency period. This type of model
is called “collective stochastic escape from growth control”. In the proposed studies, we will investigate
mechanisms regulating the origin and fate of BLI cells in an effort to identify new ways to block expansion of
these cells for potential cancer prevention. We will perform functional experiments to evaluate whether targeting
activin signaling or the immune microenvironment attenuate cancer initiation, and represent actionable targets
for therapeutic development.

Public health relevance
NARRATIVE – Project 3 Patients carrying mutations in the breast cancer susceptibility gene BRCA1 have high risk of developing breast cancer, and the best preventative therapy available for these patients is risk-reducing bilateral mastectomy. Although many studies initially proposed that genome instability is the main cause of tumor initiation in BRCA1 mutation carriers, clinical observations and functional studies in animal models clearly show that non-genetic mechanisms are also critical for cancer initiation. The goal of this project is to identify and explore non-genetic drivers of disease using a combination of mathematical modeling, single cell and spatial genomics, lineage tracing and functional studies in engineered mouse models to determine the cellular and molecular basis of cancer initiation in this disease and identify new actionable targets for cancer prevention in BRCA1 mutation carriers.